Cannabinoid Modulation of Neuroinflammation in Human iPSC Models of HIV Infection

PROJECT SUMMARY / ABSTRACT
Despite effective combined antiretroviral therapies, 30-50% of people living with human
immunodeficiency virus-1 (HIV) infection experience mood, memory, learning, and/or motor disfunction,
collectively labeled HIV associated neurocognitive disorders. Mounting evidence suggests that HIV infects
brain-resident macrophages and microglia, providing a persistent reservoir for HIV replication in the central
nervous system. Because HIV does not infect neurons, the neurotoxic mechanisms driving neurocognitive
decline are likely mediated by infected glia, which become activated and secrete proinflammatory cytokines
and chemokines, neurotoxic HIV components, and excitotoxic levels of glutamate. Activation of the NLRP3
inflammasome, an NF-κB-driven assembly that facilitates IL-1β and IL-18 release and initiates pyroptosis, has
been identified as an HIV-induced mediator of neurotoxicity. Recent studies suggest that NLRP3 activation is
suppressed by activation of cannabinoid receptor 2 (CB2), an immunomodulatory GPCR which has been
separately identified as a neuroprotective target in in vitro HIV models. I hypothesize that CB2 agonism
decreases HIV-associated macrophage/microglial activation and macrophage/microglia-mediated neurotoxicity
by suppressing the NLRP3 inflammasome. This proposal leverages primary human monocyte-derived
macrophages (MDMs) in parallel with human induced pluripotent stem cells (iPSC) differentiated into microglia
(iMg) and glutamatergic cortical neurons to understand the cell-specific effects of CB2 agonists on HIV infection
and subsequent neuroinflammation. This will be accomplished in three aims: (I) identify how CB2 agonism
effects macrophage and microglial infection dynamics, broad pro-inflammatory activation, and
endocannabinoid system component expression in human models exposed to intact HIV, (II) specifically
determine the effects of CB2 agonism on NLRP3 inflammasome priming, assembly, and pro-inflammatory
cytokine release, and (III) examine whether CB2 agonism is protective against indirect macrophage- and
microglia-mediated neurotoxicity, and whether that protection occurs via modulation of the NLRP3
inflammasome. These studies will increase our understanding of the effects of cannabinoid exposure in HIV-
induced neuroinflammation and determine whether CB2 is a potential therapeutic target for NLRP3
inflammasome suppression in HIV infection and other pathologic neuroinflammatory contexts.

Public health relevance
PROJECT NARRATIVE Despite antiretroviral therapy, human immunodeficiency virus-1 (HIV) persistently infects macrophages and microglia, resulting in activation of neurotoxic proinflammatory pathways. This proposal aims to determine whether cannabinoid receptor 2 (CB2) agonists can act as effective modulators of HIV-induced macrophage and microglial activation and subsequent neurotoxicity in human cell models. Successful completion of this proposal would further our understanding of the immunomodulatory effects of cannabinoid exposure in neuroHIV and potentially identify CB2 as a valid target for anti-inflammatory therapeutics in HIV infection and other pathologic neuroinflammatory states.